Tracheostomy and Laryngectomy Care: Virtual Reality Training for Health Professionals

Project Summary/Abstract
The goal of the project is to develop an innovative virtual reality (VR) curriculum to train students and novice
clinicians in nursing, medicine, and allied health professions such as speech-language pathology (SLP) to
provide team-based care of the airway and voice for cancer patients who have a tracheostomy or a
laryngectomy. Three aims are addressed. Aim 1 is to finalize curriculum content and the VR modules, working
from cases and VR objects created in our work to date. Aim 2 assess the content validity and user experience
of the VR curriculum from the perspective of clinical experts and from learners. Aim 3 develops assessment
rubrics to accompany the curriculum so that performance in the VR simulations can be evaluated. The overall
approach is an iterative process initiated by the project personnel who will further develop preliminary content
in three areas that ultimately become distinct VR modules: 1) foundational knowledge of anatomy, physiology
and relevant medical supplies for airway and voicing care; 2) routine care of the airway and voicing in those
with tracheostomy or laryngectomy; and 3) urgent/emergency care of the airway and voicing in these
populations. The preliminary curriculum content is independently reviewed by a clinical advisory committee
(CAC) leading to revisions by the study team. This process of CAC review, feedback and revision is repeated.
The VR development team builds and refines the VR environments and scenarios as an alpha version of the
VR curriculum comprised of three modules. The alpha versions are also evaluated in an iterative process by
the clinical advisory committee for accuracy, fidelity, and completeness; and user feedback from learners is
obtained regarding VR usability, technical issues, and potential negative user experiences. Additionally, learner
assessment rubrics will be developed in Aim 3 to accompany the curriculum; these will be designed to evaluate
interprofessional practice skills and clinical knowledge and abilities in managing the airway and voicing during
the VR simulations. Development of the rubrics will include determining inter-observer agreement of clinical
instructors observing learners completing the VR modules. Achieving the project aims will result in a VR
curriculum comprised of the three VR modules, a curriculum manual, and rubrics for assessment of learners
engaged in the simulations. This curriculum can then be assessed for learning outcomes on a broader scale in
future projects focused on deploying the curriculum to students and novice clinicians in various settings such
as graduate schools, residency training programs, and emergency medical technician programs. A better
prepared healthcare workforce ultimately will be created to support airway and voicing needs of cancer
patients with a tracheostomy or a laryngectomy resulting in improved health and quality of life outcomes.

Public health relevance
PROJECT NARRATIVE This project will create an innovative virtual reality curriculum allowing teams of nursing, medicine, and allied health care students and clinicians to gain clinical knowledge and skills in providing care for the airway and voicing needs of people with cancer who have a tracheostomy or a laryngectomy (that is, total removal of the voice box). This curriculum will be evaluated by clinical experts for accuracy, realism, and completeness and nursing, medicine, and speech-language pathology students will provide feedback on the user experience in the VR training. Creation and eventual distribution of the VR curriculum for broader testing across multiple training programs will result in a better prepared healthcare workforce to manage breathing and voicing issues in people with a tracheostomy or a laryngectomy.